Impact of ovarian hormone suppression on regional and global brain architecture and cognition

PROJECT SUMMARY
In women, reproductive aging is marked by a dramatic decline in ovarian hormone production, and is a time
when many women report changes in memory and attention. Animal studies provide powerful evidence that
ovarian hormones, in particular 17β-estradiol, play a critical role in shaping the morphology and function of
brain regions that are central to higher order cognitive processes and cognitive aging. The degree to which
female reproductive aging leads to macrostructural changes in human brain morphology, changes in brain
connectivity, and ultimately changes in cognitive functioning represents a significant knowledge gap that has
yet to be adequately examined. Ovarian hormone suppression (OHS), a widely used treatment for
endometriosis, offers a unique clinical scenario through which to study the impact of estrogen and
progesterone changes on the brain and cognition. The treatment allows for the temporary and reversible
induction of a postmenopausal-like endocrine status, the effects of which can be observed over the course of a
few months, and offers a human analogue of animal studies that have provided substantial evidence for the
neuroprotective effects of ovarian hormones and their influence on neural function. In the proposed
observational study, we will examine 200 adult women with endometriosis (ages 25 to 40), half of whom will
undergo OHS via the gonadotropin releasing hormone (GnRH) antagonist Elagolix, and half of whom will follow
a non-hormonal treatment plan, in order to gain critical insights into how the depletion of ovarian hormones
impacts the brain and cognition. Women will be examined pre-treatment and at 6 months post-baseline to
characterize the progression of changes in response to OHS. In Aim 1, we will characterize the effects of OHS
on cognitive functioning. We will employ a comprehensive neuropsychological battery to assess changes in
cognition brought on by OHS. In Aim 2, we will utilize state-of-the-field neuroimaging techniques to
characterize the impact of OHS on structural brain measures, specifically targeting subfields of the
hippocampus, the entorhinal cortex, and white matter pathways using diffusion spectrum imaging. In Aim 3,
we will use resting state and task-based fMRI paradigms to determine the effects of OHS on global and
regional brain networks. We hypothesize that OHS will impact intrinsic correlations in the default mode,
frontoparietal, and limbic networks at rest, and alter prefrontal cortex efficiency during working memory.
Finally, in Aim 4, we will test whether polygenic risk for Alzheimer’s disease modifies the effects of OHS on the
brain and cognition. The multimodal cognitive neuroscience approach will allows us to model a core aspect of
reproductive aging, ovarian hormone depletion, while holding chronological age relatively fixed. This project
will clarify the role of ovarian hormones in shaping brain architecture and cognitive functioning, a severely
understudied arena in cognitive neuroscience with clear implications for women’s health.

Public health relevance
PROJECT NARRATIVE The degree to which female reproductive aging leads to macrostructural changes in brain morphology, brain connectivity, and ultimately cognitive functioning is severely understudied. By examining cognitively normal women undergoing ovarian hormone suppression for endometriosis, the present study will model a core aspect of reproductive aging, providing critical insights into how the depletion of ovarian hormones impacts the brain and cognition. This unique, genetically informed, cognitive neuroscience approach will advance our knowledge of the endocrine basis of cognition and facilitate a targeted approach to identifying individuals who may be particularly vulnerable to neural and cognitive effects of ovarian hormone depletion.